RESEARCH DIAGNOSTIC CRITERIA-- RELIABILITY AND VALIDITY

in instruction on page 6. Appendix (Five collated sets. No page numberin necessaryfor A pendix.) ZKidfxis Appendix I: Research Diagnostic Criteria for femporomandibuEr Disorders: Criteria, included Examination and Specifications/Critique Appendix 11: Data Collection Protocol and Study Forms Appendix 111: Calibration Procedure for Reliability Testing Appendix IV: Additional Basic-ScienceReferences PHS398 (Rev. 5/95) (FOP~age 3) Page 4: cc Number pages consecutively at the bottom throughout the application. Do Mt use suffixes such as 3a, 3b.